The economic and social impact of pandemic mitigation policies: A cross-country analysis of macro events

The project, "The economic and social impact of pandemic mitigation policies: A cross-country analysis of macro events," will explore the economic and social effects the mitigation policies and information environment that the pandemic spawned. We will link those policies to data from ongoing household-based panel studies from 10 countries and rich administrative data from an eleventh. We will exploit the substantial intra and inter-country temporal and geographic variation in non-pharmacological intervention policies induced by the pandemic disease. That variation, coupled with pre-pandemic baseline levels or long-running trends in the outcomes we will study, will identify the effects of the mitigation policies.

Public health relevance
The project "The economic and social impact of pandemic mitigation policies: A cross-country analysis of macro events" will explore the economic and social effects of the mitigation policies and information environment that the pandemic spawned. We will link the policies to individual panel data and exploit the substantial temporal and geographic variation, in and across countries, in non-pharmacological intervention policies induced by the pandemic virus.